Understanding the in vivo impact of immunotherapies in splenic lymphoma by intravital three-photon microscopy

Diffuse large B cell lymphoma (DLBCL) and the follicular lymphoma (FL) are the most common lymphoid
malignancy in adults. EZH2 mutant occurs in DLBCL and FL patients. Immunotherapies, EZH2 inhibitor and CAR
T cells are FDA approved for FL and DLBCL, respectively. Understanding why patients respond or are resistant
to the immunotherapies is essential for these approaches to reach their full potential. However, it is unclear
whether the mechanism of EZH2i action is cell autonomous or through restoration of immune surveillance and
how EZH2i affects the ability of CAR T cells to kill lymphoma because there has not been visualized the process
of immune surveillance against lymphoma in vivo. In particular, the white pulps of mouse spleen, key regions of
lymphomagenesis, are challenging to visualize in vivo due to the limited imaging penetration depth of
conventional two-photon (2P) microscopy. Leveraging deep tissue imaging capability of three-photon (3P)
microscopy that provides twice deeper imaging depth than 2P microscopy, we aim to in vivo visualize the dynamic
interplay of lymphoma B cells with their microenvironments and CAR T cells in the spleen upon EZH2i treatment.
To this end, we propose the following specific aims: (1) develop simultaneous 6-color and longitudinal 3P
microscopy approach for intravital imaging of the white pulps in mouse spleen and (2) perform the intravital 3P
microscopy for understanding the impact of EZH2 inhibitors on reactivation of anti-lymphoma response and their
impact on enhancing CAR T cell therapy. In Aim 1, first of all, we will determine permissible laser parameters to
optimize the imaging speed for tracking individual immune cell migration in a mouse spleen because high
average power and pulse energy of laser excitation required for deep and fast imaging can cause thermal and
focal damages. Second, we will develop an implantable chronic imaging window for longitudinal imaging of
mouse spleen for several weeks to several months. Third, we will develop simultaneous 6-color 3P imaging
system to visualize the interaction among 6 different cell types by adding 2 more detection channels in the current
4-color 3P imaging system. In Aim 2, we will perform the simultaneous 6-color and longitudinal 3P microscopy
to visualize the dynamic interaction of lymphoma B cells with helper T cells, regulatory T cells, CD8 effector T
cells, follicular dendritic cells, and blood vessels in the spleen of syngeneic lymphoma mouse model upon EZH2i
or control vehicle treatment. In addition, we will also visualize the interplay of lymphoma B cells with CAR T cells
and the following apoptosis of the tumor cells upon EZH2i or vehicle treatment to understand how EZH2i affects
the ability of CAR T cell to kill the tumor cells. Collectively, this study will demonstrate 6-color and longitudinal
3P microscopy for intravital imaging of the splenic immune system with tumors, for the first time. The imaging
results will provide the first direct evidence for the nature of the anti-lymphoma immune response and the manner
in which lymphomas evade host immune cells and CART cells, allowing us to generate new hypotheses for the
design of combination immune therapies.

Public health relevance
Understanding why lymphoma patients respond or are resistant to state-of-the-art immune therapies is essential for these approaches to reach their full potential. To understand the impact of immune therapies on direct tumor killing and reactivation of the immune system, we propose to directly visualize in vivo the dynamic interplay of lymphoma B cells with their microenvironments in the spleen of the syngeneic mouse model upon immune therapies by 6- color and longitudinal three-photon microscopy. This study will provide the first direct evidence for the nature of the anti-lymphoma immune response and the manner in which lymphomas evade host immune cells and CAR T cells, allowing us to generate new hypotheses for the design of combination immune therapies.